Administrative Core

Core B will ensure the smooth operation of the Program Project, functioning in both both scientific and financial administration.

Public health relevance
Proper administration will enable all Pis and researchers to make maximum progress.